Systems genomics approach to targeting glucose toxicity during pathological cardiomyocyte hypoxia

Project Abstract
The heart is an obligate aerobic organ, making it one of the highest oxygen consumers of any organ in the body.
Cardiac dependence on oxidative metabolism makes the heart particularly vulnerable to oxygen insufficiency,
which is observed in many diseases including ischemic heart disease and heart failure, as well as pulmonary
pathologies such as chronic obstructive pulmonary disease. These constitute the leading causes of morbidity
and mortality in the world. The heart retains some ability to adapt to mild hypoxia, indicating that protective
pathways exist that could be harnessed to improve cardiac function in patients with chronic hypoxia pathologies.
Cardiomyocytes (CMs)—the parenchymal cell type of the heart—are metabolically flexible and can shift their
fuel source preference in response to hypoxia. This plasticity suggests that interventions that rewire CM
metabolic pathways can reduce tissue damage. However, our ability to design such interventions is currently
limited by our understanding of the molecular mediators of these metabolic changes. This proposal aims to gain
a systems-level understanding of the pathways that facilitate adaptive and maladaptive metabolic changes in
CMs in response to hypoxia, with the long-term goal of targeting these pathways as novel therapeutics. To
accomplish this, I have developed a functional genomics platform in iPSC-CMs. In a preliminary genome-wide
CRISPRi survival screen in iPSC-CMs in chronic hypoxia, my initial findings paradoxically suggest that
suppressing excessive accumulation of intracellular glucose may be protective in hypoxia. Interestingly, a related
clinical phenomenon supports this general concept – hyperglycemia at the time of ICU admission has been
shown to correlate with worse outcomes following MI or cardiac arrest, independent of diabetes status. These
findings suggest that shifting fuel sources is a central component of the (mal)adaptive hypoxic response. I
hypothesize that modulation of hypoxia-responsive fuel rewiring can serve as a therapeutic strategy to restore
CM function during cardiac pathologies caused by oxygen deprivation. I will test this hypothesis through three
separate aims. First, I will systematically identify the regulators of cardiomyocyte survival in pathological hypoxia
using a functional genomics screen. By creating nutrient limiting conditions, I will determine the pathways that
enable substrate switching in hypoxia. Second, I will determine the metabolic fates of glucose during CM hypoxia
using isotope tracer studies. Third, I will target glucose uptake and processing pathways genetically to restore
CM survival and electrophysiology during pathological hypoxia. These experiments will identify novel therapeutic
targets related to fuel rewiring in CMs and will provide mechanistic insights into cardiac glucose toxicity to enable
a further understanding of the pathophysiology of cardiac hypoxia.

Public health relevance
Project Narrative Cardiac hypoxia is a prominent contributor to the pathophysiology of a myriad of cardiac diseases, constituting the leading causes of morbidity and mortality in the world. Cardiomyocytes have an innate ability to adapt to mild hypoxia through fuel switching over chronic timescales, however, the molecular mediators of this transition have not been fully elucidated. The goal of this proposal is to gain a comprehensive understanding of the pathways that facilitate adaptive and maladaptive metabolic rewiring (particularly for fuel use) in hypoxic CMs, with the long-term goal of targeting these pathways as novel therapeutics.